Effects of Electrical Stimulation and Vitamin D supplementation on Bone Health Following Spinal Cord Injury.

Project Summary/Abstract
Neurogenic osteoporosis is a devastating problem that is likely to impact 46,000
Veterans with chronic spinal cord injury (SCI). It is typically associated with low impact fractures
of long bones and other medical comorbidities. It is estimated that approximately fifty percent of
all individuals with SCI will develop low impact fracture during their lifetime. The management of
osteoporosis related fractures can impose substantial economic burden on the health care
system, individuals with SCI and their families. Advancement in medical research clearly
indicated that neurogenic osteoporosis is linked to reduced loading and Vitamin D (Vit D)
deficiency. Our pilot work indicated that a simple rehabilitation paradigm targeting towards
evoking skeletal muscle hypertrophy may attenuate deterioration in trabecular bone parameters
after SCI. Evoked resistance training (RT) using surface neuromuscular electrical stimulation
(NMES) has been shown as a successful and feasible home-based approach to load skeletal
muscles after SCI. Our earlier results may imply long term compliance and adherence if
successfully applied in conjunction with a telehealth approach. In the present study, we propose
a simple home-based approach of using NMES RT in conjunction with oral Vit D
supplementation on trabecular bone quality in 20 Veterans with chronic SCI. Data will include
measurements of trabecular bone quality as determined by magnetic resonance imaging (MRI)
and bone biomarkers associated with the process of bone remodeling.
Twenty participants with chronic (> 1-year post-injury) motor complete (AIS A and B) SCI
(18 to 65 years of age) will be randomly assigned into either NMES RT plus 2000IU of Vit D (10
participants) or passive movement plus 2000IU Vit D (10 participants) to participate in a
repeated measure design trial for 9 months. The NMES RT plus Vit D will undergo 4.5 months
of open kinematic chain resistance training followed by 4.5 months of closed kinematic chain
using simple rowing approach. This pilot work will have two main specific aims. Aim 1. To
determine the impact of home based NMES RT protocol plus oral Vit D supplementation
compared to passive movement plus oral Vit D on bone microarchitectural properties. Aim 2.
To determine the impact of home based NMES RT protocol plus oral Vit D compared to passive
movement and Vit D supplementation on biomarkers of bone formation and bone resorption.
Key words: Spinal cord injury, osteoporosis, bone turnover, bone remodeling, bone biomarkers,
electrical stimulation, vitamin D.

Public health relevance
Neurogenic osteoporosis is a common complication of spinal cord injury (SCI) that is associated with low impact bone fractures. It is concerning that more than 46,000 Veterans affected with SCI and are at risk of osteoporosis and possible low impact fractures. About fifty percent of all individuals with SCI will develop low impact fracture in their life time. The management of osteoporosis-related fractures can impose substantial economic burden on the health care system, the individual and the families. Previous studies did not succeed in reversing the process of bone loss after SCI. In the present pilot study, we will evaluate the effect of Neuromuscular Electrical Stimulation Resistance Training in combination with oral Vitamin D supplementation, on bone quality in Veterans with chronic SCI, using a randomized experimental design.